Aggressive colorectal cancer subtypes and social disadvantage in a racially diverse cohort

ABSTRACT
While overall colorectal cancer (CRC) incidence and mortality have declined over the last several decades,
CRC incidence and mortality rates continue to be higher in African Americans (AAs) than non-Hispanic Whites
(NHW). Consensus CRC molecular tumor subtypes are important indicators of carcinogenic pathway and
prognosis, and area associated with specific somatic gene mutations, mismatch repair (MMR) phenotype, and
gene-specific methylation, although it is currently unknown whether racial differences in these subtypes
underlie racial disparities in CRC survival as these subtypes were derived from studies largely comprised of
NHW CRCs. The relative contributions of genetic, behavioral and environmental factors on CRC-related
outcomes in AA individuals remain largely unknown and there is a critical need for information about
pathogenesis to improve approaches to screening and treatment. This is especially true for area-level
socioeconomic factors, such as income and housing values, that are associated with higher risk of CRC but for
which the biologic consequences are not yet known. The overall goal of the study is to identify genomic and
social factors associated with CRC pathogenesis in a well-characterized cohort of AA CRC cases. We
hypothesize that tumor biology, here defined by somatic and epigenetic alterations in tumors, explains a
substantial proportion of the racial disparities in CRC outcomes, and area-level factors modify this relationship.
Our long-term goal is to improve our ability to diagnose, treat and prevent CRC through a comprehensive
understanding of the molecular events in tumors that arise in diverse populations.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is one of the most incident cancers in the United States. African Americans have higher incidence of colorectal cancer compared to non-Hispanic whites, with worse prognosis. This study will identify biologic pathways that differ in colorectal cancers that arise in African Americans.